Acquisition of an automated protein crystallization imager

PROJECT SUMMARY/ABSTRACT
This proposal requests funds to purchase a Formulatrix Rock Imager® 1000 automated crystal tray imager
with 500-tray capacity and dual light path capable of both visible light, ultraviolet (UV) and multi-fluorescence
imaging. The new imager will make it possible to monitor trays for crystal growth, capture images and log trays
in high throughput. This instrument will greatly enhance efforts to crystallize and determine structures of
biological macromolecules of high biological importance and will accelerate progress in drug discovery and
immunotherapy. The imager will be housed in a Macromolecular Crystallography core in the Department of
Biophysics and Biophysical Chemisry in the Johns Hopkins University School of Medicine, which also houses a
Mosquito® LCP liquid handler for setting up crystallization trials in high throughout. The visible and UV l multi-
fluorescence imaging capabilities of the Rock Imager will enhance users’ ability to locate very small crystals in
precipitates and lipidic cubic phase, as well as distinguish protein crystals from salt. The Rock Imager will
greatly benefit the research of six Major and five Minor users, all of whom have experience with crystallization
and x-ray crystal structure determination. The user group includes leading structural biologists as well as
investigators who utilize structural studies as a component of their research programs. The crystal imager will
greatly accelerate progress in multiple projects that are currently supported by 16 NIH grants, and include
studies of biological macromolecules involved in transcription regulation, DNA replication, DNA repair,
oncogenesis, and the inflammatory response, as well as translational studies that utilize structure-guided
design of novel immunotherapeutics. The long-term support of the imager and Macromolecular Crystallography
core will be ensured by the Department of Biophysics and Biophysical Chemistry, which has managed and
subsidized this structural biology resource for more than three decades.

Public health relevance
PROJECT NARRATIVE The requested Rock Imager 1000 automated crystal imager will facilitate high-throughput screening for crystallization of biologically important macromolecular complexes. This instrument will accelerate progress in determining structures of macromolecules implicated in cancer, neurodegeneration, inflammation, and immunotherapy, and will accelerate efforts in structure-based drug discovery.